REPRODUCTIVE BIOCHEMISTRY AND MEDICINE

The experiments carried out under the plans for the Specialized Population Research Centers grant are concerned with the biochemistry of steroid and polypeptide hormones, the investigation of ovarian and adreno-cortical steroid pathways, primate neuroendocrine control of reproduction, and biochemical and genetical aspects of infertile human males.